Investigating the role of epitranscriptomic A-to-I RNA editing in T-cell acute lymphoblastic leukemia

Project Summary The ultimate goal of this proposal is to address a compelling unmet medical need to identify novel epitranscriptomic mechanisms of oncogenic transformation that will guide development of diagnostic and therapeutic strategies capable of predicting and preventing progression of T-cell acute lymphoblastic leukemia (T-ALL). Acute lymphoblastic leukemia (ALL) is the most prevalent hematological cancer in children younger than 14 years of age. Despite progress in intensive chemotherapy, 20-25% of pediatric and over 50% of adult patients show resistance to therapy and relapse. Widespread aberrant epitranscriptomic ADAR1-mediated adenosine-to-inosine (A-to-I) RNA editing has been associated with clinical characteristics of several cancer types and generation of leukemia initiating cells (LICs) with enhanced pro-survival and self-renewal capacity. Interestingly, activation of janus kinase (JAK)/STAT signaling by interleukin-7 (IL-7) drives expression of key stem cell regulatory pathway ADAR1-LIN28 and pro-survival factors in hematological malignancies including T-ALL. Our central hypothesis is that mutational pro-inflammatory signals, such as NOTCH and JAK/STAT signaling pathway, induce aberrant RNA editing driven by ADAR1 activation in T-ALL-initiating cells that accentuated by enhanced survival and self-renewal capacity. The three specific aims will be (1) examine if the ADAR1-mediated RNA editing promotes oncogenic transformation of normal T cell progenitor to T-ALL LICs by enhancing T-ALL LIC survival and self-renewal pathways; (2); examine whether ADAR1 activity is enhanced in T-ALL LIC cells due to NOTCH or JAK/STAT signaling pathway activation, and lastly (3) determine whether direct inhibition of ADAR1 activity by shRNA strategy impairs the survival and self-renewal impairs T-ALL LIC maintenance. This proposal will utilize established biorepository of primary T-ALL patient specimen, along with age-matched healthy control samples. In addition, lentiviral-based tools and established robust in vivo human xenograft T-ALL mouse models will be used for selective ablation of ADAR1 transcripts to thoroughly investigate the relationship between ADAR1 expression and generation of drug-resistant T- ALL-initiating LIC cells. Detailed functional and mechanistic lentiviral-directed transcript overexpression and knockdown studies will validate sensitive whole transcriptome RNA-Sequencing that correlate ADAR1 expression with LIC survival and self-renewal signaling pathway and stem cell gene expression signatures. This research strategy is uniquely integrated into my career development plan, including additional trainings in data management, basic and translational research, research ethics, and professional and leadership development. By providing a more mechanistic understanding of the role of ADAR1 in cancer, this grant will inform future RNA editase detection and inhibition strategies that may help to obviate cancer resistance and relapse.

Public health relevance
PROJECT NARRATIVE Acute lymphoblastic leukemia (ALL) is the most prevalent hematological cancer in children younger than 14 years of age and despite progress in intensive chemotherapy, 20-25% of pediatric and over 50% of adult patients show resistance to therapy and relapse. Our investigations using patient specimens will help characterize the role of epitranscriptomic A-to-I RNA editing by a self-renewal regulator ADAR1 in T-cell acute lymphoblastic leukemia (T-ALL) cancer stem cell generation and maintenance, and to test if inhibition of ADAR1 activity impairs survival and self-renewal of T-ALL leukemia initiating cells. By evaluating human-specific aberrant RNA editing as a novel therapeutic target, this proposal will contribute to our fundamental understanding of T-ALL biology and provide novel therapeutic options for patients with this disease. !